Fibronectin Extra Domain A Degradation as an Antifibrotic Approach in Lung Fibrosis

ABSTRACT
This application is for an NHLBI R03 Small Grant Award for K08 Recipients entitled “Fibronectin Extra Domain
A Degradation as an Antifibrotic Approach in Lung Fibrosis.” I am a physician in Pulmonary and Critical Care
Medicine at the University of Pittsburgh, and I am building a research program focused on the study of basic
mechanisms of lung fibrosis with a focus on host protein degradation pathways that could be exploited to mitigate
fibrosis. Pulmonary fibrosis is a sequela of several Interstitial lung diseases (ILD) and is characterized
pathologically by lung interstitial thickening and excessive deposition of extracellular matrix (ECM) components.
Clinically, the development of end-stage lung fibrosis is associated with high morbidity and mortality and the
median survival is 3-5 years in patients diagnosed with idiopathic pulmonary fibrosis. While two
pharmacotherapies are approved for pulmonary fibrosis from some ILDs, there continues to be an urgent, unmet
need for effective therapies to treat chronic fibrotic lung diseases. FN-Extra Domain A (FN-EDA) is a splice
variant of the glycoprotein Fibronectin that contains an alternatively-spliced A domain with unique properties.
FN-EDA is pathologically enriched in the ECM of patients with chronic fibrosing lung diseases, including
idiopathic pulmonary fibrosis and Systemic Sclerosis-Interstitial Lung Disease. FN-EDA is a centerpiece in the
“fibro-inflammatory” axis driving aberrant ECM deposition and is a “druggable” target in the pathogenesis of
pulmonary fibrosis. The aims of this study are 1) to determine the mechanism of FN-EDA degradation in lung
fibroblasts. We will determine if FN-EDA half-life differs in diseased vs. healthy lung fibroblasts and examine if
defects in lysosomal FN-EDA degradation account for increased FN-EDA levels in diseased fibroblasts.
Mechanistically, we will determine if the EDA domain is modified by ubiquitin to direct FN-EDA degradation. Our
second aim is to determine if the repurposed drug Lonafarnib reduces FN-EDA levels and fibrotic responses in
vitro and in vivo in a bleomycin-induced model of murine pulmonary fibrosis. We show that the drug lonafarnib
increased lysosomal activity and reduces FN-EDA levels in vitro. We will build on this data and determine IC50
values for lonafarnib in vitro in primary lung fibroblasts and human precision-cut lung slices, In vivo, we will use
an established model of bleomycin-induced pulmonary fibrosis to test if lonafarnib reduces lung fibrosis. This
proposal is a direct result of my K08-specific training plan and activities and builds on our published work
examining FN-EDA degradation. I learned high throughput screening methodologies to apply to my research
questions as part of my K08 and have developed assays for use in this proposal. This work will inform a larger,
more comprehensive R01 proposal in 24 months’ time. My work will be completed within the Division of
Pulmonary, Allergy, and Critical Care Medicine at the University of Pittsburgh, which is committed to the
development of physician-scientists.

Public health relevance
NARRATIVE We propose that degradation of the extracellular matrix protein Fibronectin-EDA (FN-EDA) could be a novel strategy to mitigate the severity of pulmonary fibrosis. I will identify mechanisms of FN-EDA degradation and test the repurposed drug Lonafarnib for its effects on FN-EDA degradation.